Trigeminal Nerve Stimulation for Prenatal Alcohol Exposure

ABSTRACT/SUMMARY
Prenatal alcohol exposure (PAE) is a severe, life-long neurodevelopmental disorder. It afflicts hundreds of
thousands of children in the US and worldwide. The highly distressing, disruptive, and disabling behavioral
symptoms of PAE include inattention, hyperactivity, and executive dysfunction, symptoms that overlap with
those of attention deficit hyperactivity disorder (ADHD). In ADHD, these symptoms are treated routinely with
stimulant medications. But children with PAE often fail to respond to stimulants, or to any therapy. There has
long been, therefore, a pressing need for new treatments for PAE. This R61/R33 proposal is about one
prospective way to meet that need. Recently, it was demonstrated at UCLA that trigeminal nerve stimulation
(TNS) is safe and effective in treating pediatric ADHD. TNS is a low-current neurostimulatory therapy that is
noninvasive, minimal-risk, and now FDA-cleared. Given the similarities PAE has with ADHD, there is a very
good (though not 100%) chance that PAE would respond to TNS as well. But, to our knowledge, TNS has
never been tested systematically in children with PAE. Here we propose the first clinical trial of TNS for PAE.
The R61 (pilot) phase will determine whether TNS is feasible for PAE: Do children with PAE comply with the
TNS procedure? Does TNS have any any serious side effects in these children? Is there an indication that
TNS relieves symptoms of PAE? If the pilot shows feasibility, as we expect it will, in the ensuing R33 phase we
will conduct a formal double-blind sham-controlled randomized clinical trial to determine rigorously whether
TNS is truly efficacious for PAE. If it is, the impact could be enormous. TNS could bring much needed relief to
children with PAE and their families everywhere. Our proposal will furthermore address the need to understand
the brain mechanisms by which TNS works, which are underexplored and largely unknown. The few studies
done to date point to three major candidate brain regions where TNS may exercise its therapeutic effects. All
three are regions where we, in prior work, detected differences between children with PAE and typically
developing children in tissue properties (“endpoints”) measured using multiple different varieties (“modalities”)
of brain MRI. These findings raise our confidence that TNS will be effective for PAE, i.e., if the brain regions
that produce PAE symptoms are the same as those acted upon by TNS, maybe TNS will quell those
symptoms. In both phases of this clinical trial we will measure the same endpoints with the same modalities of
brain MRI in children with PAE before and after TNS treatment. We will determine whether these endpoints are
changed by TNS (target engagement) and/or predict TNS clinical response (prognostic marker) in individual
patients in the three candidate regions or elsewhere in the brain. If successful, this proposal will help meet a
long-standing urgent need for novel treatments for PAE and will help clarify the currently mysterious brain
mechanisms of an emerging pediatric neurostimulatory therapy.

Public health relevance
NARRATIVE Prenatal alcohol exposure (PAE) is common and highly disabling in children and poorly responsive to treatment. ADHD has similar symptoms to PAE and a safe, well-tolerated new therapy for ADHD—trigeminal nerve stimulation (TNS)—has emerged in the last few years. We propose, for the first time, to conduct a formal clinical trial of TNS for children with PAE to measure behavioral changes and to study where in the brain TNS might be exerting its effects using neuroimaging.